Metabolomics Technologies to Advance Biomedical Research

Project Summary
The success of our R35 has resulted in the implementation of the XCMS-METLIN online informatic platform,
an effort that has been decades in the making. This technology, especially with the incorporation of METLIN’s
MS/MS data, is causing explosive growth in the number of registered users, now over 50,000. To support this
growing user base, we request support for a more advanced server system with the primary purpose to
leverage this new breakthrough technology. This resource will remain freely available to the 50,000 plus
registered users worldwide and has been previously supported by Scripps with over $200,000 in internal
funding. This supplement will also help meet the strategic plan of the NIGMS MIRA grant program to support
ambitious projects, move research into new directions, improve our research productivity, and effectively
mentor the next generation of scientists. Our efforts have been extremely effective in establishing new
scientists in metabolomics with new faculty at Yale University, Washington University, University of Colorado,
Imperial College London, University of Lausanne, Montana State University, Colorado State University, as well
as many others, and the research described here will continue to facilitate the mentoring environment
important to the MIRA program. As a part of the research described herein, we request a supplement to
support the acquisition of new computer server hardware for our new XCMS-METLIN platform, a
groundbreaking technology that will impact the entire community.
1

Public health relevance
Project Narrative The success of our R35 has resulted in the implementation of the XCMS-METLIN online informatic platform, an effort that has been decades in the making. This technology, especially with the incorporation of METLIN’s MS/MS data, is causing explosive growth in the number of registered users, now over 50,000. To support this growing user base, we request support for a more advanced server system with the primary purpose to leverage this new breakthrough technology.